Center for Community Health: Addressing Regional Maryland Environmental Determinants of Disease

ABSTRACT (OVERALL)
The Johns Hopkins University (JHU) proposes the creation of the Center for Community Health: Addressing
Regional Maryland Environmental Determinants of Diseases (CHARMED). The strategic vision of the Center
is to serve as the nexus of community-engaged environmental research at JHU and in the Maryland region
(Washington DC, Baltimore (referred to as CHARM City) and Pennsylvania) by providing focus, research, and
leadership for promotion of transformative environmental health science research that will improve human health.
The overarching mission is to understand how exposures to environmental factors cause adverse health
outcomes and then to translate these findings into action to protect and promote the health and well-being of
vulnerable communities in the Maryland region. This mission has been informed by and will continue to be guided
by strong partnerships between community leaders and CHARMED members (59) drawn from the JHU and the
University of Maryland at College Park. The synergistic combination of basic, population and community-
engagement scientists within CHARMED promotes translational research that addresses fundamental questions
and translates knowledge into action to have a major impact on human health in the Maryland region, consistent
with the NIEHS Strategic Plan. Our mission is accomplished through five aims. Aim 1: Advance translational
environmental health research that will improve community health outcomes in the Maryland region as it relates
to the thematic foci of the Center. The Thematic Research Groups are: 1) Cardiorespiratory Health and Airborne
Contaminants; 2) Chemical Mixtures and Emerging Contaminants, and Health; 3) Community, Social, and
Environmental Determinants of Health; and 4) Neurological Health. Aim 2. Promote translation of data to
knowledge to action by creating and strengthening strategic partnerships with communities and stakeholders to
address environmental health challenges and help set the research agenda of CHARMED using community-
engaged research approaches (Community Engagement Core). Aim 3. Establish and support a facility core
structure [Integrated Health Sciences Facility Core (IHSFC), and Exposure Characterization and Modeling
Facility Core (ECMC)] that enables the mission. The IHSFC will provide assistance with human subject study
design, and employ biostatistical, big data, and bioinformatic analyses and integrate “omics” including
metabolomics data to predict adverse outcomes. Aim 4. Build capacity in environmental health through a
comprehensive strategy that includes fostering (career development, Core Workshops), and supporting (ESI
Mentored Scholars Program, pilot funds, access to facility cores) both early stage and senior investigators
conducting community environmental health research for the first time. Harnessing the scientific capacity of the
Center will facilitate translation of the Center’s research findings into evidence-based approaches for
environmental exposure mitigation and disease prevention to improve human health in Maryland and beyond.

Public health relevance
NARRATIVE (OVERALL) The Center of Community Health: Addressing Regional Maryland Environmental Determinants of Disease (CHARMED) conducts research to discover the links between environmental exposures and adverse health outcomes, and then to translate these findings into action to improve the health of vulnerable individuals in communities across the Maryland region and beyond. Bi-directional communication with the Community through the Community Engagement Core will guide the research directions of CHARMED and inform public health decision making.